Vgamma2Vdelta2 T cell recognition of HIV-infected cells in the lung

? DESCRIPTION (provided by applicant): Cardiopulmonary disease is a leading cause of death for HIV patients in the US. Chronic inflammation and immunodeficiency persist even during effective anti-retroviral therapy and virus suppression. Eliminating latent infection is a major barrier to reducing co-morbidity, eradicating HIV and achieving a cure for AIDS. HIV viremia results in extensive depletion of effector γδ T cells and reduces patients' ability to combat co-infections and chronic inflammation. Gammadelta T cells, activated by clinically approved bisphosphonate agents, recognize and kill HIV-infected T cells, as well as inflammatory macrophages, through direct or indirect cytolysis. We found that activated γδ T cells also have the capacity to recognize and kill latently infected cells with little or no active virus replicatin. Immunotherapy targeting γδ T cells may help treat the chronic inflammation seen in HIV-associated cardiopulmonary disease, in addition to eradicating latent infection. Our aims are to define γδ T cell surface receptors and target cell ligands involved in recognitio of latently infected cells and test strategies for improving target cell destruction. Clinical trias for cancer immunotherapy test the anti-tumor properties of γδ T cell expansion after bisphosphonate plus IL-2 therapy. In Aim I, we use this immunotherapy strategy to test for γδ T cell cytotoxicity against latently infected CD4 T cell targets and characterize the mechanisms of recognition. In Aim II, we evaluate the γδ T cell deficiencies in cytotoxic recognition seen in HV infection. In Aim III, we test strategies to further improve γδ T cell recognition and killing of latently infected targets. This pilot study will test the ability to exploit the unique capacities f γδ T cells to kill infected HIV cells, which may be achieved with approved drugs, and seek to eradicate the viral reservoir and provide a functional cure for AIDS.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cardiopulmonary disease is a leading cause of death in patients with HIV and is caused by chronic lung inflammation due to inappropriate immune activation and the failure to resist lung infections due to immune system damage. A key cell type important for normal lung immunity is the gamma delta T cell, which is depleted and damaged during HIV infection. We will conduct pilot studies that enhance the unique capacity of gamma delta T cells to kill latently infected HIV cells and seek to eradicate the viral reservoir to provde a functional cure for AIDS.